Coordinated mental simulation in the hippocampus and primary visual cortex during active behavior

PROJECT SUMMARY / ABSTRACT
Our sensory experience goes beyond what is immediately in front of us, as evident when we recall memories
or imagine future scenarios. These “mental simulations”, operationally defined as neural representation of
states or stimuli that do not refer to actual present experience, are supported by a distributed circuit in the
mammalian brain. Dysfunctions of this network could lead to psychiatric illnesses that affect sensory
perception, like schizophrenia. Previous work shows that two key loci in this circuit are the hippocampus
(HPC), a cognitive area that encodes space, and the primary visual cortex (V1), a sensory area that processes
visual input. The goal of this proposal is to investigate how these regions interact to generate coordinated
mental simulations during active behavior. To achieve this goal, this proposal combines innovative tools like
flexible neural probes to obtain stable chronic recordings in these regions in freely moving rats and applies
advanced state-space algorithms to read out a common cognitive variable from them with a high temporal
resolution. Preliminary data shows that the animal’s position decoded from V1 moves ahead or behind the
actual position by as much as ~ 15 cm. Furthermore, this is correlated with position decoded from HPC,
indicating coordinated mental simulation across these regions. Aim 1 (K99) will test the generality of this
coordination by changing external factors such as visual features and geometry of the environment. Aim 2
(K99/R00) will study the feedforward mechanism underlying coordinated mental simulations by examining the
head and eye movements as well as comparing receptive field properties and laminar location of V1 neurons
to their spatial tuning. Aim 3 (K99 pilot/R00) will identify the feedback mechanism underlying coordinated
mental simulations by conducting the experiments in the dark to isolate the top-down influence and
optogenetically silencing HPC to block its feedback to V1. This work will build on the candidate’s extensive
expertise in visual neuroscience, electrophysiology, and quantitative data analysis by providing training in four
key scientific areas, under primary mentor Loren Frank: (1) gaining a deeper understanding of the decoding
algorithm with the guidance of advisor Uri Eden; (2) refining techniques for applying flexible neural probe with
the guidance of advisor Chong Xie; (3) training in freely moving visual neurophysiology; and (4) learning
optogenetic manipulation techniques, both with the guidance of co-mentor Massimo Scanziani. The training
plan will build professional skills in mentorship, lab management and scientific communication to propel the
transition to independence. UCSF offers a collaborative and supportive environment to pursue cutting-edge
research in systems neuroscience and launch an independent career. The proposed work will provide key
insights into the neural basis of mental simulations and build a foundation for the candidate’s long-term goal: to
understand how the brain forms an internal model of the world from sensory information and uses it to guide
behavior.

Public health relevance
PROJECT NARRATIVE The brain can travel in space and time to generate representations that do not refer to the current experience (“mental simulations”), a remarkable capability supported by distributed neural circuits in the mammalian brain including the hippocampus and primary visual cortex. To address our limited understanding of the neural mechanism underlying mental simulations, this proposal will leverage cutting-edge experimental and computational tools to decode a common cognitive variable from the hippocampus and primary visual cortex and examine the factors that influence their remarkable coordination. This work will enhance our knowledge of how the cognitive brain influences the sensory brain and provide insights into psychiatric disorders that affect visual perception, such as schizophrenia.